Identifying Undiagnosed Airway Dysfunction in WTC Responders Using Respiratory Oscillometry

Project Summary
Rescue/recovery work at the World Trade Center (WTC) disaster site is associated with many physical health
outcomes, including respiratory conditions.1-10 While over 6,230 of the Fire Department of the City of New York
(FDNY) WTC-exposed rescue/recovery workers have a diagnosis of obstructive airway disease (OAD),
preliminary analyses show 43% with respiratory symptoms do not have a clear diagnosis to explain their
symptoms, leaving an area of diagnostic and treatment uncertainty. Although spirometry is the most common
pulmonary function test used to evaluate WTC-exposed individuals, many with respiratory symptoms have
normal spirometry. Several studies in WTC-exposed community members and ironworkers have suggested that
persistent respiratory symptoms after WTC exposure are likely due to small airway dysfunction (i.e., airways <2
mm in diameter) which is not well characterized using spirometry.11-20 Alternatively, respiratory oscillometry is a
non-invasive, effort independent, low-cost method for measuring the mechanical properties of the respiratory
system that is especially useful in measuring small airway function. Beginning in 2013, a subset of FDNY
rescue/recovery workers underwent respiratory oscillometry testing and spirometry, both performed on the same
day. Our proposed study is an opportunity to analyze these data and explore if abnormal respiratory oscillometry
measurements, including small airway measurements, explain the reason for respiratory symptoms in the FDNY
cohort who remain without a clear respiratory diagnosis; thereby, potentially expanding upon current findings in
WTC-exposed community member and ironworker cohorts. Specifically, we will focus on those with normal
spirometry who have respiratory symptoms, thus, continue to have diagnostic uncertainty. In these cases, normal
spirometry results present challenges in diagnosing and treating conditions like asthma and chronic obstructive
pulmonary disease (COPD), highlighting the need for alternate testing modalities to diagnose airway dysfunction.
This proposal aims to determine if respiratory oscillometry can identify airway dysfunction among symptomatic
WTC-exposed FDNY responders with diagnostic uncertainty. By resolving this uncertainty, earlier treatment
interventions could be implemented, potentially reducing respiratory symptom-related morbidities. First, we will
examine the relationship between airway resistance, as measured by respiratory oscillometry, and respiratory
symptom characteristics and severity. Then, we will investigate if abnormal respiratory oscillometry, in those with
normal baseline spirometry measured at the same time, predicts future spirometry abnormalities. Because OAD
treatment modalities can differ based on the presence of eosinophilia, we will also explore if blood eosinophilia
is associated with abnormal respiratory oscillometry in individuals with normal spirometry. By carrying out this
proposed project we will address diagnostic uncertainty in airway dysfunction among WTC-exposed individuals.

Public health relevance
Project Narrative Over 40% of Fire Department of the City of New York (FDNY) WTC-exposed rescue/recovery workers have respiratory symptoms but have normal spirometry, leaving an area of diagnostic and treatment uncertainty. It has been suggested in non-FDNY cohorts that persistent respiratory symptoms after WTC exposure, in those with normal spirometry, are likely due to small airway dysfunction which is better measured using respiratory oscillometry. The proposed study will investigate if airway dysfunction, as measured by respiratory oscillometry, could explain the reason for respiratory symptoms in the FDNY cohort; thereby, potentially expanding upon findings in WTC-exposed community member and worker cohorts.